A Data Resource for Analyzing Blood and Marrow Transplants

PROJECT SUMMARY/ABSTRACT
The Center for International Blood and Marrow Transplant Research (CIBMTR) is a clinical research program
dedicated to addressing important issues in the field of hematopoietic cell transplantation (HCT). CIBMTR
maintains a large outcomes registry with information for >475,000 HCT recipients in >420 centers and provides
statistical support for analyzing those data. A separately funded Research Repository of donor-recipient
specimens linked to these clinical data is available for a large subset of patients, as are data generated from
analyses of these specimens, including high-resolution human leukocyte antigen (HLA) data and whole
genome sequencing. Use of this Resource by thousands of investigators around the world during the current
and previous funding cycles have contributed to >1,100 publications on important issues, to improved global
collaboration in data exchange and HCT research and to increase the amount of data available to providers
and patients for clinical decision-making. With renewal of U24-CA76518, CIBMTR will continue to build on the
infrastructure made possible by this support to facilitate in-depth exploration of clinical, immunologic, genetic,
quality of life, and health services issues related to HCT. This application proposes to enhance this Resource
and to advance its utility through the following Specific Aims:
Resource Development: Maintain and enhance CIBMTR’s high-quality clinical database and state-of-the-art
statistical support to address important issues in HCT and related fields through continued development of
state-of-the-art data collection, management and sharing technologies and procedures, expansion of
infrastructure to capture patient-reported outcomes and cellular therapies, development and application of
novel statistical techniques, and collaboration with national and international networks in HCT and related
fields.
Resource Utilization: Increase use of data and statistical resources maintained by the CIBMTR to support
studies in malignant and non-malignant diseases with important clinical and policy implications, and enhance
processes to prioritize and complete these studies.

Public health relevance
PROJECT NARRATIVE The CIBMTR plays a unique and important role in facilitating clinical research in HCT and cellular therapy. It is committed to developing its research database and statistical capabilities to meet the needs of investigators in a rapidly evolving field. It will build on the infrastructure made possible by support from U24-CA76518 and its partnerships to better serve the research and healthcare community and to address issues important to patients.